Developmental Research Program

PROJECT SUMMARY (Developmental Research Program)
The specific objectives of the Developmental Research Program are to:
1. Publicize the availability of funds for pilot translational leukemia research studies.
2. Identify through this mechanism innovative projects with significant potential for improving leukemia therapy
and prognosis.
3. Encourage collaborations of projects with scientists within the SPORE and outside the SPORE.
4. Enhance the communication between the SPORE leaders and outside investigators to encourage the
development of innovative translational strategies in leukemia.
5. Ensure program flexibility so that developmental projects that show promise can be: 1) funded for a second
year; 2) encouraged to apply for peer-reviewed funding (i.e. R01); or 3) expanded to become full SPORE
projects.
The Leukemia SPORE has established, over the past 14 years, clear guidelines and processes for solicitation,
selection, and monitoring of the Developmental Research Awards. To achieve our aims, we have developed
1) specific criteria for selection and funding through a peer review mechanism, and 2) mechanisms for close
monitoring of, and collaboration between the SPORE leaders and program awardees to enhance the quality of
the translational research goals. This resulted in 47 awards given to 34 researchers. The seed money allowed
the majority of the funded investigators to pursue independent research in leukemia with peer-reviewed
funding. Because of the success of these established mechanisms, we propose to continue them in the next
funding period.

Public health relevance
PROJECT NARRATIVE (Developmental Research Program) The Developmental Research Program aims to support and develop leukemia research projects with a translational potential that will ultimately improve the prognosis, the survival and cure rates, and the quality of life of patients with leukemia.